OPERATE THE DTP BIOLOGICAL DATA PROCESSING SYSTEM

Operate and maintain the DTP Biological Data Processing System. Prepare reports of the results of the many screening systems used by DTP. Also change the system as new test systems are developed and/or new reports are developed.